Role of ICP0 Dimerization in Herpes Simplex Virus Pathogenesis

PROJECT SUMMARY
Herpes simplex virus (HSV) infections can result in life-long oral, ocular, and genital infections that lead to
debilitating diseases such as blindness and life-threatening encephalitis. A key aspect of HSV pathogenesis is
the ability of the virus to establish a latent infection in sensory neurons, for which repeated reactivations result
in viral replication and cellular damage and leads to HSV-mediated diseases. Understanding the components
and processes that control latency and reactivation is essential to developing novel and effective therapeutics.
A key viral component in controlling the latency-reactivation cycle is the immediate-early protein of HSV known
as infected cell protein 0 (ICP0). ICP0 is an E3 ubiquitin (Ub) ligase that significantly enhances the expression
of all 3 HSV gene classes required for efficient lytic replication and viral reactivation from latency. Importantly,
the transactivation function of ICP0 is linked to dimerization via its C-terminal domain. Genetic studies indicate
that ICP0's dimerization/C-terminal domain significantly enhances viral replication and pathogenesis in an
animal model of HSV latency and reactivation. Surprisingly, there is very limited information regarding the
mechanisms associated with ICP0 protein-protein interaction/dimerization process and function of ICP0. The
long-term goal of this proposal is to understand the interactions among and between viral factors and to relate
findings from these studies to recurrent herpetic diseases. As an important step in this direction, the X-ray
crystal structure of ICP0 dimers has been solved; this structure of ICP0 dimers is a novel fold, as there are no
structural homologs in the Protein Data Base. The objective of this application to identify mechanisms by which
ICP0 binds to itself to enhance viral transcription. The central hypothesis is that specific C-terminal residues
on ICP0 facilitate its dimerization to stimulate its (own) Ub ligase activity, viral gene expression, and productive
infection. The rationale for these studies is the concept that structural knowledge of ICP0 and its dimer
interface will allow one to understand how this viral protein controls lytic infection and reactivation. To test this
hypothesis the following Specific Aims are proposed - Aim 1: Identify ICP0-ICP0 dimerization contacts that
stimulate HSV gene expression. Aim 2: Determine the contribution of ICP0 dimerization in HSV-1 replication
and pathogenesis. Work from this study is significant and innovative as it will provide the first known molecular
structure of a large functional domain for HSV-1 ICP0, uncover at least one mechanism of ICP0 dimer
formation, and ascertain how ICP0 self-interactions modulate it key activities and pathogenesis. Results from
project can be compared to other herpesviruses that encode orthologs that are functionally similar to ICP0.

Public health relevance
PROJECT NARRATIVE This project is related to public health as it will examine the structure of a pivotal viral protein involved the in replication and pathogenesis of herpes simplex virus. Results from this proposal can be used to develop new therapies for preventing or treating herpetic diseases, which is within NIH’s mission to promote scientific discovery while enhancing human health.